Reprograming Macrophages and Targeting Glioma Stem Cells in Glioblastoma

Project Summary
Glioblastoma (GBM) is the most lethal primary brain tumor with poor prognosis. GBM contains heterogeneous
cancer cells including glioma stem cells (GSCs) and harbors abundant tumor-associated macrophages
(TAMs). Because the majority of TAMs are tumor-promoting macrophages (pTAMs, M2) that support malignant
growth and augment immune suppression, reprograming pTAMs into tumor-suppressive TAMs (sTAMs, M1) to
activate macrophage phagocytosis of tumor cells represents an attractive therapeutic strategy. As pTAMs
actively interact with GSCs to promote tumor growth and therapeutic resistance, redirecting pTAMs into sTAMs
may synergize with targeting GSCs to suppress GBM growth. To discover small molecules that can reprogram
pTAMs into sTAMs to stimulate macrophage phagocytosis of glioma cells, we designed a phagocytosis
fluorescent screening assay, using GFP-labeled human iPSC-derived macrophages and tdTomato-expressing
glioma cells including GSCs to identify drug candidates and the potential molecular targets. To this end, we
identified several inhibitors of BACE1 (β-site amyloid precursor protein cleaving enzyme 1) as top candidates,
and thus defined BACE1 as a molecular target to redirect pTAMs into sTAMs. Our studies demonstrated that
BACE1 is preferentially expressed by pTAMs in human GBMs and required for maintaining pTAM polarization.
Inhibiting BACE1 by its inhibitor MK-8931 potently reprogramed pTAMs into sTAMs and promoted macrophage
phagocytosis of glioma cells to suppress GBM growth. Moreover, we found that low-dose radiation (IR)
markedly enhanced TAM infiltration into GBM and synergized with MK-8931 treatment. As MK-8931, initially
developed for Alzheimer's disease, has been shown to be safe for patients in clinical trials, MK-8931 can be
potentially streamlined for the macrophage-based tumor therapy. In addition, we previously found that the non-
receptor tyrosine kinase BMX maintains GSC tumorigenic potential by mediating STAT3 hyper-activation, and
demonstrated that targeting BMX with ibrutinib potently suppressed GBM growth and impaired radioresistance.
Because both ibrutinib and MK-8931 penetrate the blood-brain barrier (BBB) or the blood-tumor barrier (BTB)
very well, repurposing ibrutinib and MK-8931 for GBM treatment should be straightforward and have promising
potential. Based on these studies, we hypothesize that redirecting pTAMs into sTAMs by MK-9831
synergizes with targeting GSCs by ibrutinib to suppress malignant growth and thus improves GBM
treatment. We will accomplish our objectives through the following Aims: (1) We will assess the effect of
reprograming pTAMs into sTAMs on cytokine profile, GSCs, and GSC-derived pericytes in GBM; and (2) We
will evaluate the therapeutic impact of reprograming pTAMs to sTAMs and targeting GSCs for GBM treatment.
The outcomes from the proposed pre-clinical studies will determine whether synergistically reprograming TAMs
and targeting GSCs can serve as a novel therapeutic strategy to effectively improve GBM treatment, which will
inform future clinical trials.

Public health relevance
Project Narrative Glioblastoma (GBM) is the most common and lethal type of primary brain tumor that is highly resistant to current treatments, indicating that development of new effective therapeutic approaches is urgently needed. Because both glioma stem cells (GSCs) and the tumor-promoting macrophages (pTAMs, M2) promotes malignant growth and therapeutic resistance, synergistically targeting GSCs and reprograming pTAMs into tumor-suppressive macrophages (sTAMs, M1) may significantly improve GBM treatment. In this proposal, we will assess whether redirecting pTAMs into sTAMs through BACE1 inhibition by MK-8931 in combination with targeting GSCs through BMX inhibition by ibrutinib can serve as a novel strategy to significantly improve GBM treatment.